Mechanisms and strategies to rescue suboptimal T cell priming in colon cancer

PROJECT SUMMARY/ABSTRACT
I propose to functionally interrogate mechanisms of cancer immune evasion and immunotherapy resistance
in powerful new mouse models of colorectal cancer (CRC). Immune checkpoint blockade (ICB) has
revolutionized treatment of multiple solid tumor types but is nevertheless ineffective in most cancers. I
hypothesize that this is due in part to distinct programs of T cell dysfunction that respond poorly to ICB, such
as that programmed by suboptimal T cell priming. While microsatellite instable (MSI) CRC responds remarkably
well to ICB, likely due to a high burden of mutation-derived antigens (neoantigens), most CRC (~88%) is
microsatellite stable (MSS) and does not respond. However, MSS CRC is characterized by a higher burden of
mutations than other solid tumor types that do respond to ICB, like kidney cancer. My own analysis of human
MSS CRC sequencing revealed that all tumors expressed at least two clonal neoantigens with strong predicted
binding to HLA-I, but that these neoantigens were expressed at significantly lower levels than those in MSI CRC.
This suggests that neoantigen expression levels, in addition to burden, may play an important role in the
antitumor T cell response. To test this, I developed a colonoscopy-guided orthotopic transplant model of CRC
employing isogenic organoids with varying levels of expression of model CD8+ T cell neoantigens. High
expression resulted in organoid rejection, while low expression resulted in poor T cell priming with immediate
dysfunction and tumor escape. Tumor infiltrating T cells in my low neoantigen-expressing model and human
MSS CRC showed signatures of tolerogenic dysfunction, distinct from canonical “exhaustion” and consistent
with suboptimal priming. These analyses also identified the orphan nuclear receptor 4A subfamily genes Nr4a1,
Nr4a2, and Nr4a3—an exciting new class of T cell checkpoint—as potentially central mediators of this process.
Aim 1 will functionally interrogate Nr4a1-3 in T cell priming and dysfunction and investigate their potential as
therapeutic targets in CRC. Aim 2 will determine whether existing therapies that boost T cell priming (CD40
agonism, vaccination) can rescue suboptimal T cell priming in CRC and delineate T cell intrinsic and extrinsic
mechanisms of efficacy and resistance. The overarching goal of these aims is to deepen our mechanistic
understanding of non-canonical T cell dysfunction in CRC and identify new therapeutic strategies to reverse it.
This holds substantial promise for the majority of CRC and other cancers that do not respond to ICB and may
guide novel combination clinical trials. This proposal is innovative in bringing together cutting-edge mouse
models of cancer and advanced tools in immunology. Its completion should bring clarity to the outstanding
question of why CRC, the second leading cause of cancer deaths worldwide, is generally nonresponsive to
current immunotherapies. The K22 award will help me execute these aims and generate preliminary data that
will form a foundation for competitive R01 applications, publications, and a successful independent research
program, as well as give me the flexibility to augment my immunology training through NASDC course offerings.

Public health relevance
PROJECT NARRATIVE Despite remarkable clinical success of immune checkpoint blockade in a range of cancers, most colorectal cancer (CRC) patients do not respond to these treatments. Using powerful new mouse models of CRC and cutting-edge tools in immunology, I propose to deeply investigate T cell dysfunction programmed by suboptimal priming. This project aims to delineate mechanisms of efficacy and resistance to therapies targeting the T cell priming axis, with the goal of guiding clinical investigation of novel combination immunotherapies for CRC.